Alcohol tolerance encoding in sleep and memory circuits

Project Summary / Abstract
A single acute ethanol exposure causes lasting changes in behavior and brain function. Acute changes may
form a basis for progressive changes with subsequent ethanol exposures, incrementally increasing the risk of
alcohol use disorder. Studies from humans to Drosophila have uncovered strong behavioral and neural links
between the development of ethanol tolerance, an early form of ethanol-induced plasticity, and changes in
sleep. We recently discovered in Drosophila that a small group of circadian clock neurons that regulate sleep
also encode rapid ethanol tolerance, the form of tolerance that is closely associated with proximal changes in
sleep. Whereas prior work in Drosophila implicated clock pacemaker genes and a potential relationship
between sleep and rapid tolerance, our new data provides an anatomical locus and a focus on the specific
aspects of the tolerance/sleep interaction. The long-term goal is to determine how ethanol causes changes in
sleep. The expected long-term impact is a better understanding of the relation between addiction and sleep.
Because rapid ethanol tolerance appears to map to some but not all sleep regulatory neurons, we
hypothesize that ethanol may ‘misuse’ sleep circuitry.
Circadian rhythms and sleep are extensively studied in Drosophila. While our understanding of rapid ethanol
tolerance is less complete, it is easy to study and intriguing underlying mechanisms are beginning to emerge.
The density of data on sleep mechanisms in Drosophila and mammals creates an opportunity to better
understand tolerance and its relation to longer term effects of ethanol.
The plan for this proposal is to determine the extent of co-encoding of rapid ethanol tolerance and sleep in
Drosophila. To do this, we propose three experiments. First, we plan to map rapid ethanol tolerance in sleep
circuitry. Second, we discovered that rapid ethanol tolerance is composed of a labile and a consolidated
memory-like states. We plan to map these and also evolutionarily conserved tolerance genes in the sleep
circuitry. Third, We plan to survey the function of the approximately 50 known sleep genes in rapid ethanol
tolerance. The majority of these genes have not yet been tested for their role in tolerance.
The expected outcome of the proposed research is a genetic and circuit map of rapid tolerance with respect to
sleep.

Public health relevance
PROJECT NARRATIVE Binge drinking both induces ethanol tolerance and has complex and lasting effects on sleep. We and others discovered clues that sleep genes and brain circuits encode aspects of ethanol tolerance. Our goal is to determine the extent of the genetic and circuit overlap; our results will lead to in-depth understanding of the tolerance:sleep relationship and potentially point to ways to manage alcohol's effects on sleep.